Development and Function of Medulla Tangential Neurons

The process by which the brain is assembled into an organized structure in which cell bodies, axon
tracts, and dense synaptic neuropils occupy consistent locations is not well understood. In particular, the
potential role of tangentially projecting neurons in organizing brain structure merits further investigation.
Transient tangential pioneers in the subplate of the developing human cortex are thought to establish a
framework for long-range connections, and defects in these neurons have been implicated in the
pathogenesis of neurodevelopmental disorders. Tangentially projecting neurons can more readily be studied
in the Drosophila visual system, which is amenable to rapid genetic analysis. Recent advances in
understanding cell fate specification, gene expression in individual cell types, and connectivity have made
this a relatively well described model system in which to address developmental and functional questions.
However, visual projection neurons in the largest optic lobe, the medulla, have been excluded from many of
these analyses. Recent results show that Plexin A provided by these tangentially projecting neurons
organizes the layered structure of the medulla neuropil, emphasizing their importance for optic lobe
assembly. This exploratory proposal will focus on characterizing the development and function of medulla
visual projection (MeVP) neurons. The first aim will use lineage tracing to determine which neuroblasts give
rise to MeVP neurons. As MeVP neurons constitute a small subset of all medulla neurons, these cells will be
partially purified to facilitate a targeted transcriptomic analysis of their gene expression profiles. The results of
this analysis will in turn enable the development of further tools that can be used to study and manipulate
MeVP neurons. The second aim will investigate the mechanisms that direct MeVP neurons to send dendritic
projections perpendicularly to the majority of medulla neurons and axonal projections into the central brain.
Transgenic RNAi will be used to deplete guidance receptors that are expressed in these neurons and the
effects on their projections will be examined. In addition, targeted ablation of MeVP neurons or their
processes will reveal whether they provide cues other than Plexin A to organize the medulla neuropil. If so,
these cues will be identified by RNAi knockdown of candidate transmembrane or secreted proteins derived
from the transcriptomic analysis in Aim 1. Integrating this class of neurons into current models of the
development of the visual circuitry will provide a more complete description of the system, and will potentially
shed light on the role of tangentially projecting neurons in the developing human brain.

Public health relevance
Narrative A small population of neurons in the brain send their projections in a direction perpendicular to most other neurons; in humans, defects in these cells are implicated in the development of schizophrenia and autism. Our studies using the Drosophila visual system suggest that this class of neurons has an important role in organizing the overall structure of the brain. This proposal will explore how these tangential neurons develop, what genes they express, and how they influence other neurons to affect brain organization.